Cloud implementation of Xenbase the Xenopus model organism knowledgebase

PROJECT SUMMARY
Xenbase.org, the Xenopus model organism knowledgebase, is a web accessible resource that integrates the
vast and diverse genomic and biological data from Xenopus research. The parent award to this supplement
application is 2P41HD064556, 5/13/2021-04/30/2026 (PIs AM Zorn and PD Vize). Our mission is to accelerate
the translation of Xenopus research into knowledge that will improve human health. We aim to empower
Xenopus research and enhance the impact of Xenopus data in the broader biomedical community. Animal
models such as Xenopus are essential for biomedical research and have led to a wealth of discoveries. In this
post genomic era with thousands of scientific publications annually and the exponential growth of “omic”
datasets, resources such as Xenbase are essential to translate this vast body of data into meaningful biological
syntheses. Xenbase is the only central repository for the enormous amount of data generated from research
using Xenopus. Our relational database and user-friendly interface allow investigators to quickly interrogate
and link different data types in ways that would otherwise be difficult, time consuming, or impossible. Xenbase
implements the FAIR data management principles that aim to make data findable, accessible, interoperable
and reusable. Xenbase enhances the value of Xenopus data through high quality curation, ontology
development, data integration, bioinformatics tools optimized for Xenopus experiments, and by linking
Xenopus data to humans and other model organisms. Xenbase plays an indispensable role in making
Xenopus data accessible to the broader biomedical community by continually providing annotated data
updates to many organizations such as NCBI, UniProt, Ensembl the Alliance of Genome Resources (AGR)
and other model organism knowledgebases (MOKs). Xenbase has over 1,800 registered users with ~1 million
pageviews a year and ~50 unique visitors per weekday. The goals of the parent grant are to:
Aim1 Maintain Xenbase, Curate and Disseminate Xenopus research data
Aim 2 Enhance support for Xenopus models of human diseases
Aim 3 Enhance Integrated Omics support
The goal of this administrative supplement is to migrate Xenbase from a suite of physical virtual machines to a
public AWS cloud. We will then perform a series of reiterative tests and improvements to enhance system
reliability, performance, security and enhance large-scale data tools.

Public health relevance
PROJECT NARRATIVE The goal of this administrative supplement is to migrate Xenbase, the Xenopus model organism knowledgebase (2P41HD064556), from a suite of physical virtual machines to an AWS public cloud. Xenbase is only the resource supporting the vast array of genomic and biological data from Xenopus providing annotated data updates to organizations such as NCBI, UniProt, Ensembl the Alliance of Genome Resources (and other model organism knowledgebases. We will migrate Xenbase to the cloud and with reiterative testing improve system reliability, performance, security and enhance large-scale data tools.